Alcohol Regulation of Endothelial Plasticity in Atherosclerosis

Abstract
Cardiovascular disease is the leading cause of death globally. Studies show that low-to-moderate alcohol
consumption is protective against cardiovascular disease, whereas heavy binge drinking and chronic abuse is
harmful. Currently lacking, however, is in-depth knowledge of the mechanisms involved. In particular,
understanding the cell and molecular processes mediating the protective effects of alcohol is of great interest
and could lead to novel therapies for cardiovascular disease.
Most of the problems associated with cardiovascular disease are caused by arteriosclerosis, a thickening
and stiffening of artery walls, that may lead to blood flow blockage resulting in heart attack or stroke.
Arteriosclerosis develops in areas where the endothelial lining becomes activated or damaged in response to
injurious stimuli. Emerging evidence suggests that endothelial cells, by undergoing a change in phenotype to a
myofibroblast in a process known as endothelial-to-mesenchymal transition (EndMT), may themselves be key
drivers of arteriosclerosis. This raises the exciting possibility of a novel cell mechanism involved in vascular
pathology. Crucially, no information exists as to whether alcohol, a known modulator of cardiovascular disease,
might regulate EndMT in this context, a question of considerable interest and the focus of our exploratory
proposal.
We have previously reported that daily moderate alcohol (EtOH) consumption reduces arteriosclerosis,
while heavy binge consumption worsens it, and that EtOH stimulates Notch signaling in vascular endothelial
cells. Our recently published study and our preliminary data demonstrate that EtOH at moderate levels acts to
maintain endothelium in a beneficial ‘non-activated’ state. Moreover, our preliminary data are suggestive of a j-
shaped relationship between EtOH and transforming growth factor-beta (TGFb)-induced EndMT of arterial
endothelial cells, with lower doses of EtOH inhibiting and higher doses stimulating EC transition.
Thus, the overall hypothesis of our proposal is that low-moderate alcohol consumption prevents
endothelial activation, limiting EndMT in a Notch-dependent manner, thus, maintaining vessel homeostasis and
protecting against arteriosclerosis, whereas binge drinking increases endothelial activation resulting in greater
EndMT and exacerbated lesions. We will use human endothelial cells exposed to atherogenic stimuli in vitro, in
combination with single cell RNA-sequencing (scRNA-seq) analyses of endothelial cells from a mouse model of
arteriosclerosis to test our hypothesis and elucidate the mechanisms involved. Our novel study will illuminate
how ‘healthy’ and ‘harmful’ alcohol consumption differentially impacts arteriosclerosis by affecting endothelial
cell plasticity. These data potentially have important clinical implications with regard to prevention, treatment,
and regression of cardiovascular disease.

Public health relevance
Project narrative Consuming alcoholic drinks can have effects, good and bad, on cardiovascular disease that is a leading cause of death. Our study will investigate how alcohol (different amounts, and different patterns of consumption) affects endothelial activation and transformation, processes believed critical to atherosclerotic lesion development. Deciphering the precise cellular and molecular mechanisms mediating alcohol’s cardiovascular health effects will fill a crucial knowledge gap and is highly significant from both basic science and clinical viewpoints.